Coordination Component

Coordination
PROJECT SUMMARY / ABSTRACT
The Coordination Component of the Center for Somatic Cell Genome Editing in Nonhuman Primates provides
overall administrative management to ensure efficient processes, policies, and procedures; cost-effectiveness;
accessibility; achievement of milestones; and coordination of productive collaborations and partnering across
the Testing Center and with investigators nationwide, other testing centers, and the NIH. The Coordination
Component is the administrative home for the Nonhuman Primate Testing Center and will assure an effective
approach to successfully meet the overall goals and objectives. The Coordination Component will ensure the
cohesion of all aspects of the program with investigators, including regular communications; a user-friendly
application process; review and selection of projects; and timely study conduct and reporting. The Coordination
Component will evaluate progress and plans with the assistance of the Steering Committee and External
Advisory Board, and make certain information is provided on a regular basis to the research community and
the NIH. These goals and objectives will be accomplished through the following Specific Aims: (1) Provide
administrative support and overall management of the Testing Center; (2) Implement a fair and equitable
process with procedures for submission, review, and selection of projects for conduct in the Testing Center;
and (3) Facilitate communications and data sharing across Testing Center components, investigators, other
testing centers, the greater research community, and the NIH. The Coordination Component includes a
multidisciplinary team of leaders and collaborating investigators that will be guided by a governance structure
that ensures the team overall will set priorities based on informed decisions, and with fair and equitable
resource management and distribution. The Nonhuman Primate Testing Center leadership team, Steering
Committee, and External Advisory Board, with foundational UC Davis infrastructure support (e.g., California
National Primate Research Center, Genome Center, Clinical and Translational Science Center), will anchor the
program. The Coordination Component will provide the essential support, resources, expertise, and
partnerships for a well-organized and managed program that meets all goals and milestones, and thereby
addresses the broader research community interests and needs.